Core 1: Pathology core

Project Summary/Abstract
The Pathology Core provides pathology and laboratory support for all SPORE projects including collection,
prioritization, distribution and interrogation of both human prostate tissue and mouse models of prostate cancer
(PCa). The Core collects and annotates diverse specimens, including fresh, frozen and formalin-fixed human
tissue, biopsies including surveillance biopsies. The Core constructs tissue mircroarrays, processes whole mount
and regular tissue blocks and tissue sections, and collects serum, plasma and urine for the analysis of DNA,
RNA and protein. All specimens are collected at UCLA, Cedars-Sinai Medical Center (CSMC) and Greater LA
VA Medical Center (GLA VA) in accordance with institutional guidelines and following established protocols with
informed consent and patient confidentiality protected. Biospecimen repositories and data resources from the 3
sites are virtually integrated into a single unit. Through database infrastructure, collected bio-materials are linked
to the clinical database at the parent institution and virtually integrated so that pathological, clinical, and family
history data are available across institutions to maximize their potential use in translational research. Finally, the
Pathology Core is responsible for prioritizing the access to all Core materials, with preference given to SPORE
investigators.
The Pathology Core is fully integrated with the Jonsson Cancer Center translational pathology core laboratory
to avoid duplication of services and consolidate resources. Integrative services include enumeration and
characterization of circulating tumor cells (CTCs) in a novel nanotechnology-based platform co-developed by
the core, preparation of live epithelial cells from fresh human prostate tissue, laser-capture microdissection,
digital pathology, quantitative immunohistochemistry (IHC) and immunofluorescence (IF) as well as multiplex
immunohistochemistry. The core uses whole mount sections to correlate pathologic findings with imaging
studies. Several specialized techniques to increase the knowledge gained from tissues are provided by the Core,
such as multiplex immunohistochemical localization of proteins and RNA, laser capture microscopy, 3-
dimensional visualization of cells in tissues through tissue clearing and light-sheet microscopy and computerized
digital image analysis to quantify the cellular content and tissue architecture in pathology slides. In this context,
the Pathology Core has the capacity to generate datasets from hematoxylin and eosin (H&E) and IHC/IF slides
using whole slide digital scanning with machine learning and deep learning pipelines. The resulting data format
is well suited for integration with other “OMICS” data (i.e. genomics, proteomics, etc.). The large repertoire of
available services is tailored to support each individual project or career development award. The Pathology
Core has heavily invested in developing and acquiring new technologies to solve problems related to the
procurement and analysis of all pathological specimens.

Public health relevance
Project Narrative The Pathology Core is integral to prostate cancer research at 3 institutions (UCLA, Cedars Sinai Medical Center, and Greater West Los Angeles-VA) in order to better diagnose and treat prostate cancer across all demographic groups. The Core is integrated with all SPORE projects and is responsible for collection, prioritization, distribution and interrogation of both human prostate tissue and mouse models of prostate cancer. All protocols are standardized across 3 institutions and SPORE sites are virtually connected, and the core is able to perform a menu of specialized innovative techniques for tissue analysis including digital image analysis and multiplex immunohistochemistry.